Novel Probes of the Kappa Opioid Receptor: Chemistry, Pharmacology, and Biology

Project Summary
We propose to develop new kappa opioid receptor (KOR) agonists that have diverse signaling profiles with the
goal of correlating cellular signaling properties to favorable properties (antipruritic, anxiolytic and non-sedating)
in mice. The KOR is an attractive drug target because drugs that activate KOR do not lead to overdose or
addiction. However, drugs that act at KOR have had their own side effects that have hampered their use
clinically. These include diuresis, dysphoria and sedation. Our prior work has introduced new probe compounds
that raise the possibility that the therapeutic effects may be separated from the side effects. Compound triazole
1.1 is a potent KOR agonist that activates GTPγS binding in cells and in mouse striatum with the same potency
and efficacy as a standard KOR agonist, U50,488H. U50,488 is potent and efficacious at inducing KOR
activation across several signaling platforms, including βarrestin2 recruitment. However, triazole 1.1 is far less
potent in recruiting βarrestin2 recruitment, and has been shown to be a biased agonist at KOR (bias factor >20).
We and others have shown that triazole 1.1 produces antinociception and suppresses pruritis in rodents, yet is
devoid of sedating and dysphoria-like properties. Others have shown that triazole 1.1 suppresses oxycodone-
induced itch in nonhuman primates and decreases oxycodone self-administration in rats. Therefore, we propose
that selective, G protein signaling biased KOR agonists may be a means to preserve desirable effects and avoid
side effects. This proposal seeks 5 years of support to generate diverse chemical probes in order to test the
extent of this correlation (does biased agonism = less side effects). We introduce two new chemical scaffolds
to build upon our already extensive structure-activity relationship collection. We will fully characterize the
pharmacological properties of the compounds across functionally diverse cell-based assays with of a goal of
identifying compounds capable of fine-tuning KOR responsiveness. Cell-based responses will be validated in
mouse models assessing locomotor responses, suppressing pruritis (itch response), diuresis, and measures of
anxiolytic-like behaviors to determine that compound maintains the pharmacological profiles in vivo. Compounds
will also be tested in combination with morphine. Probe compounds that show favorable behavioral profiles will
be used to explore differential KOR signaling in mouse striatum and striatal neurons. Our enthusiastic team
consists of established medicinal and synthetic chemists, a structural biologist, and an opioid
neuropharmacologist (with both molecular and behavioral pharmacology expertise). The development of
pharmacological tools across diverse pharmacophores and correlating their properties with in vivo response
profiles will provide guiding evidence of the optimal chemical and pharmacological properties required to refine
KOR-targeting therapeutics.

Public health relevance
Narrative Chronic drug abuse, addiction, anxiety and depression leads to neurological changes in dopaminergic structures in the brain. Kappa opioid receptors are located on neurons that modulate pain, itch and dopamine tone and may present a means to provide therapeutics to treat these conditions and modulate neurological processes. This proposal will introduce new chemical means to regulate the KOR and provide essential preclinical optimization required to understand the best way to make kappa opioid receptor-targeted drugs with fewer side effects.